FY25 FACILITIES TASK ORDER A - REPLACE WOOD STREET STEAM & CONDENSATE PIPING

This project will replace the steam and condensate piping on Wood Street
from MH 5-35 to MH 5-16A due to the age and leaks of the pipes in that area.
The existing piping system consists of the 10” High Pressure Steam Line and
6” Pumped Condensate Main Line running overhead from the South and
running into Steam Vault MH5-35 and MH5-16A. The High-Pressure Steam
and Condensate Lines run North along Wood Street ending at Steam Vault
MH 9-16B and feeding Building 550.